An Engineered CRISPR System for Boosting Tumor Immunogenicity.

PROJECT SUMMARY
The discovery of cancer immunosurveillance and the subsequent development of cancer immunotherapy
represent a major breakthrough in clinical oncology. Immune checkpoint inhibitors can block the
immunosuppressive interaction between T cells and tumor cells, thereby activating the immune system to
eliminate cancer. Currently more than 3,000 clinical trials are undergoing around the world to evaluate T cell
modulators, which accounts for approximately 2/3 of all oncology trials. Despite their remarkable clinical efficacy,
immune checkpoint inhibitors fail to elicit strong immune response in the majority of cancer patients. A variety of
mechanisms have been proposed to explain the resistance to immune checkpoint inhibitors, with the most widely
accepted hypothesis centered around an immunosuppressive tumor microenvironment which results in
insufficient generation and inadequate function of tumor-specific T cells.
Activation of innate immune response, especially the 2'3'-cyclic GMP-AMP (cGAMP) synthase-stimulator
of interferon genes (cGAS-STING) pathway, provides a distinct route to manipulate the tumor microenvironment.
cGAS-STING is broadly expressed in non-immune and immune cells, serving as a direct mediator between
inflammation and pathogen infection. Small-molecule agonists of cGAS-STING have been demonstrated to
stimulate tumor immunogenicity both in vitro and in mouse models. However, small molecules cannot be
programmed with cell specificity, which may lead to prolonged inflammation and autoimmune disorders through
excessive and persistent activation of cGAS-STING signaling.
Herein, we aim to boost tumor immunogenicity by activating innate immune response selectively in the
tumor microenvironment. More specifically, we will engineer a novel RNA-targeting CRISPR system, CRISPR-
RT, to selectively and continuously synthesize RNA:DNA heteroduplex in cancer cells, which will be detected by
cGAS and promote synthesis of cGAMP. Through both intrinsic signaling in cancer cells and extrinsic crosstalk
with nearby immune cells, type I interferons and other proinflammatory cytokines will be rapidly produced,
thereby eradicating tumor cells. In this proposal, we will engineer CRISPR-RT to enable template-triggered
reverse transcription in live cells (Aim 1), target CRISPR-RT to cancer-specific transcripts to selectively
synthesize RNA:DNA heteroduplex in the cytoplasm of cancer cells (Aim 2), and evaluate cGAS-STING
activation by CRISPR-RT in vitro and using mouse xenograft models (Aim 2 and Aim 3). We envision selective
stimulation of innate immune response will alter the tumor microenvironment by promoting the maturation and
infiltration of various tumor-responsive immune cells such as CD8+ T cells, natural killer cells, and dendritic cells.
Acting independently or in combination with immune checkpoint inhibitors, CRISPR-RT may serve as
next-generation cancer immunotherapy by systematically rewiring the crosstalk between tumor cells
and the immune system.

Public health relevance
PROJECT NARRATIVE Activation of innate immune response, especially the cGAS-STING pathway, presents a distinct cancer elimination strategy in immuno-oncology. In this proposal, we aim to engineer a novel CRISPR-based platform named CRISPR-RT, which is programmed to recognize cancer-specific transcripts and continuously synthesize RNA:DNA heteroduplex in the cytosol of cancer cells, thereby activating cGAS-STING signaling selectively in the tumor microenvironment. CRISPR-RT, once developed, will serve as the first cancer-specific innate immune response-modulating therapeutic platform that can be personalized for individual patients and tumors, including those fail to respond to immune checkpoint blockades.